Georgia Comprehensive Metabolomics and Proteomics Unit for MoTrPAC

Summary
Physical exercise activates a series of molecular events in multiple tissues to meet the demand for
oxygen and substrate. Repetitive exercise causes tissue adaptation and provides broad health benefits. A
fundamental understanding of the molecular mechanisms underlying the beneficial effects of exercise at a
systems level is only beginning to be understood. The Molecular Transducers of Physical Activity Consortium
(MoTrPAC) is an NIH Common Fund initiative created to accelerate the knowledge of exercise biology by
systematically collecting detailed clinical, physiological, and molecular phenotypes in both animal models and in
a racially and ethnically diverse cohort of men and women across the age span. MoTrPAC is a highly integrated
and productive consortium organized into 5 units, each making unique contributions to populating the MoTrPAC
DataHub. MoTrPAc Components include Preclinical Animal Study Sites (PASS), Clinical Centers (CCs), the
Bioinformatics Core (BIC), the Consortium Coordinating Center (CCC) and Chemical Analysis Sites (CAS). This
proposal describes one such CAS, the Georgia Comprehensive Lipidomics Unit for MoTrPAC. Our CAS is
comprised of a team of analytical chemists, lipid biochemists, metabolomicists, systems biologists and
bioinformaticians with expertise in advanced high-throughput chemical analytics and big data, specifically
focusing on exercise-induced alterations of the lipidome.
CAS studies are divided into 3 categories, Genomics/Epigenomics/Transcriptomics, Proteomics, and
Metabolomics/Lipidomics to produce a draft molecular map of exercise. Through the Biospecimens Committee,
a tissue analysis plan (TAP) for both preclinical rats and human tissues was created and approved by the
MoTrPAC Steering Committee. CAS efforts have led to extensive molecular profiles of 6-month and 18-month-
old male and female F344 rats following both exercise training and an acute exercise bout. These data are being
analyzed by teams of MoTrPAC investigators and initial results have been submitted for publication. CAS has
also produced an initial evaluation of blood, muscle and adipose biopsy samples collected from sedentary
participants and those undergoing chronic endurance and resistance exercise training generated by the CC prior
to pause of recruitment due to the SARS-CoV2 pandemic. To complete the MoTrPAC project, CAS investigators
will continue to carry out studies with the following Specific Aims: Aim 1- to participate in consortium-wide
efforts to analyze and publish expansive multiomics data obtained from multiple tissues collected by PASS
investigators; Aim 2- to collaborate with MoTrPAC to implement temporal targeted and untargeted lipidomics
profiling of blood, muscle and adipose tissue according to the TAP; Aim 3- To perform data analysis and transfer
to the BIC through existing pipelines; Aim 4- to participate in MoTrPAC Committees, Subcommittees, and
Working Groups, perform continuous quality assurance of data, develop analytical strategies, and prepare
presentations and manuscripts to disseminate results.

Public health relevance
Narrative Prolonged or intensive physical activity has a profound effect on the lipid profiles of a variety of organs and bodily fluids. Lipidomics technologies enable these lipid changes to be accurately mapped to yield a more complete scientific understanding of how exercise affect lipids as fuels, signaling messengers and structural molecules. We will continue to serve as the MoTrPAC Chemical Analysis Site devoted to both targeted and untargeted lipidomic studies using mass spectrometry technologies, and the associated data science and bioinformatic efforts to integrate the multiomic datasets being created by the Consortium.